Identifying CXCR4 Receptor Agonists to Improve Diabetic Healing

? DESCRIPTION (provided by applicant): Impaired wound healing following injury in diabetics represents a major clinical problem, resulting in prolonged hospitalizations and significant healthcare costs. Two-thirds of all non-traumatic amputations are preceded by a diabetic wound. The development of diabetic peripheral neuropathy and decreased sensation increases the susceptibility to injury. We have shown that diabetic skin in mice and humans has impaired skin integrity at baseline which further predisposes diabetic skin to injury. Diabetic wounds are deficient in stromal derived factor-1α (SDF-1α), a potent chemokine involved in progenitor cell recruitment, angiogenesis, and granulation tissue formation, mediated through binding to the CXCR4 receptor and the establishment of a chemotactic gradient. We have shown lentiviral overexpression of SDF-1α corrects the diabetic wound healing impairment, and in exciting preliminary studies, can restore the integrity of diabetic skin. Given this important clinical problem, the objective of this proposal is to develop a small molecule therapeutics to target the SDF-1α receptor CXCR4 to improve diabetic skin integrity to prevent injury, and improve wound healing should injury occur. We have developed and optimized an innovative screening approach to identify new classes of selective CXCR4 receptor agonists that can be applied topically and penetrate the skin to improve skin integrity and wound healing. We propose to screen the full MLSMR library and carry out hit-to-lead studies to identify novel CXCR4 receptor agonists that can be developed for these complications of diabetes. Aim 1. We will Perform the MLSMR Library screen to identify molecules that can agonize the cAMP signaling pathway via the CXCR4 receptor. Using CHO-k1 cells expressing the CXCR4 receptor and a simple TR-FRET protocol to detect the cAMP response, we have developed and optimized the primary assay to screen the MLPCN library for novel, first in class CXCR4 small molecule agonists. Aim 2. We will Implement dose response studies, Validate all the Hits using a Counter-Screen, Employ secondary cell-based chemotaxis/migration assays, Confirm direct receptor binding, and Optimize our most promising molecules using SAR by Catalog and Medicinal Chemistry approaches. Hits from Aim 1 will be counter-screened for selectivity against the related CXCR5 receptor, and functional activity assessed using chemotaxis/migration assays. Cell-based binding studies using HTRF technology will confirm direct binding to the receptor, binding parameters, and optimize promising candidates by SAR. AIM 3. We will Examine the ability of Validated target molecules from Aim 2 to correct expression of microRNAs that regulate inflammation, angiogenesis, collagen synthesis, and skin integrity, that are dysregulated in diabetic skin, wounds and fibroblasts, and whose expression is corrected by SDF-1α. Target molecules from Aim 2 will be screened for their ability to correct expression of microRNA-146a, 15b, and 29a, which are dysregulated in diabetes, and corrected with SDF-1α treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: Complications of diabetes lead to impaired skin integrity and delayed wound healing, resulting in increased hospitalizations and added healthcare expense, exceeding $1.5 billion dollars annually for just diabetic foot ulcers. We have demonstrated that the impaired integrity of diabetic skin and impaired healing in diabetic wounds is associated with decreased SDF-1 production and abnormal microRNA gene expression. We have shown that treatment of diabetic skin and wounds with SDF-1 corrects these impairments, and our overall goal is to identify small molecule agonists to the SDF-1 receptor CXCR4 to improve the integrity of diabetic skin and prevent injury, as well as to improve the healing of diabetic wounds once they occur.